EFFECTS OF LONG TERM ELITE ATHLETICISM ON BONE MINERAL DENSITY

Assess the effect of elite athleticism on bone mineral density among cohort of women while adjusting for body mass index, race/ethnicity, oral contraceptive use, nutrition, menstrual status, alcohol use and tobacco use.